Aspen Lung Conference: Asthma: Pathogenesis, Phenotypes, Therapies and Gaps

PROJECT SUMMARY/ABSTRACT
With an emphasis on the integration of basic, translational, and clinical approaches, the 65th annual Aspen Lung
Conference will focus on a central question: how can knowledge of the molecular, genetic, and
environmental mechanisms that underlie the development and phenotypic diversity of asthma be
translated into more effective therapies? To address this central question, the program is organized into a
series of thematic sessions, with State of the Art speakers framing each topic. The thematic sessions will focus
on (i) the developmental origins of asthma, (ii) the role of cell biology in defining asthma endotypes, (iii)
microbiome and immune mechanisms underlying asthma pathogenesis, (iv) integrated cell and molecular
mechanisms contributing to the clinical complexity of asthma, and (v) the future of asthma therapeutics. By
addressing these topics, we seek to accomplish the following: 1) provide an international forum for leading basic,
translational, and clinical researchers to exchange ideas regarding the development and cell type specific roles
of the airway and immune system in the phenotypic and molecular manifestations of asthma; 2) stimulate
interactions between scientific fields to identify emerging and shared interests that may lead to more efficient
and productive research; 3) enhance the likelihood of success in translation of preclinical scientific advances into
direct patient benefit by developing novel strategies to better understand disease pathogenesis and implement
scientific advances in the treatment of asthma; and 4) challenge and stimulate the scientific interests of trainees
and attract a new generation of early career investigators into the broad field of asthma, as well as underlying
subdisciplines including airway and lung immune cell biology, genetics, and environmental impacts. We have
identified 12 outstanding thought leaders to present State of the Art lectures (35 min) on these topics. Each
presentation will be followed by 25 minutes of discussion - a hallmark of the Conference. The program continues
the Aspen Lung Conference’s dedication to diversity and inclusivity: n=8/13 (62%) of State of the Art
speakers/Summarizer are women, and at least 6 of our speakers are from underrepresented racial/ethnic
groups. Participation of trainees and early career faculty is facilitated by two 15-minute oral abstracts, selected
from submitted abstracts, following each State of the Art speaker (24 total). There will be two evening poster
sessions for further presentation opportunities by early career faculty and trainees. The final presentation is
provided by a Conference Summarizer, who reviews the impact and common themes of the Conference. The
Conference Summary will be published for widespread dissemination, to serve as a “think tank” that not only
summarizes the current state of the field, but also identifies key future directions for basic, translational, and
clinical asthma research. Finally, and notably, registration for the Aspen Lung Conference is free, encouraging
participation from a wide spectrum of trainees and early career investigators.

Public health relevance
PUBLIC HEALTH RELEVANCE The prevalence of asthma is increasing due to increased exposure to infectious agents and other environmental factors that impact pathogenesis. Understanding the effect of these factors on asthma development and the clinical manifestation of different asthma endotypes will have a significant impact on lung health. By highlighting emerging concepts of shared relevance to the fields of lung biology and asthma and by addressing strategies to improve translation of scientific advances to reduce the burden of asthma and other lung diseases, the 2023 Thomas L. Petty Aspen Lung Conference will promote scientific advances in asthma and ultimately improve lung health.